Task A91: Development of a Murine Model of Subcutaneous (SC) Melioidosis for Use in Vaccine Evaluation

This contract provides for the development and standardization of small animal models for infectious diseases, and may include testing of candidate products.